Remodeling of the enhancer landscape contributes to impaired muscle stem cell function during aging

In the past year, we have validated many of our genomic findings (increased immune activation and decreased collagen production) with orthogonal assays such as cytokine measurements and immunofluorescence. Currently, we are performing in vitro and in vivo experiments targeting age-related enhancers that regulate immune activation in aged muscle stem cells. Our preliminary results suggest that when old mice are treated with epigenetic inhibitors that reduce enhancer function, muscle stem cells show greater differentiation potential in vitro. In vivo experiments are ongoing.